Role of CDCP1 in the pathogenesis of autoimmune uveitis

ABSTRACT
Autoimmune uveitis is a major cause of blindness for which no cure and limited treatment options are
available. We found that CUB domain-containing protein 1 (CDCP1) knockout (KO) mice are protected from
experimental autoimmune uveitis (EAU) induced by adoptive transfer of pre-activated uveitogenic T cells,
suggesting that CDCP1 facilitates pathogenic T cell infiltration through the blood–retina barrier (BRB) to induce
EAU. In pilot mechanistic studies, we discovered that CDCP1 is selectively expressed on retinal pigmented
epithelial cells (RPEs) in the retina and identified CD71, an established T cell activation marker, as a new ligand
of CDCP1 in addition to CD6, another T cell marker. Stimulation with CD6 or CD71 induced CDCP1-mediated
RPE cytoskeletal remodeling, a process known to impair epithelial barrier functions, and increased RPE
production of IL-6, a pathogenic cytokine known to disrupt the endothelial barrier integrity. These intriguing data
provide strong evidence in support of CDCP1 as a novel immunoregulator that interacts with CD6 and CD71 on
T cells to facilitate pathogenic T cell infiltration through the BRB to induce EAU. Further, our data suggest that
CDCP1 could be targeted for treating autoimmune uveitis. In this proposed study, we aim to use the unique
reagents that we have developed or obtained in our preliminary studies to elucidate the detailed mechanisms by
which CDCP1 regulates both the outer and inner BRB to facilitate T cell infiltration into the retina, and to
determine the potential of CDCP1-targeted therapeutics using various conditional KO mice and our already
developed anti-CDCP1 monoclonal antibodies and nanobodies. The proposed work should provide novel
insights into our understanding of the pathogenesis of autoimmune uveitis and open new avenues of research
in which CDCP1 is explored as a key immunoregulator and new therapeutic target for this blinding disease.

Public health relevance
PROJECT NARRATIVE This project will study the mechanism by which CDCP1, a novel immunoregulator, regulates pathological T cell transmigration into the retina to induce autoimmune uveitis and evaluate CDCP1-targeted therapeutic approach for this blinding disease.